Competency-based training modules for antimicrobial stewardship and infection prevention in veterinary and veterinary nursing curricula

Improved understanding and practice of principles of antimicrobial stewardship and infection control in veterinary
medicine are urgent One Health needs. This project will more fully incorporate learning key concepts of antimicrobial
stewardship and infection control into veterinary medical and veterinary nursing curricula. The multidisciplinary team
includes two boarded veterinary clinical microbiologists, a boarded veterinary nurse (also a veterinary pharmacist), a
boarded small animal internal medicine specialist (expertise in infectious disease/infection control), and a veterinary
epidemiologist (expertise in educational epidemiology and outcomes assessment). The team has the support of the
Associate Dean for Academic Affairs, and will utilize expertise of instructional designers in the Information Technology
department.
The project proposes development of interactive learning modules and outcomes-based assessments to improve
students’ understanding of principles of antimicrobial stewardship and infection control and prevention for students in all
preclinical years of the veterinary medicine and veterinary nursing programs at Purdue University. Modules will be
integrated into existing lessons in multiple preclinical courses. The American Association of Veterinary Medical Colleges
Competency-Based Working Group has stated that educational and assessment experiences that are learner-centered,
such as those proposed here, benefit student learning, faculty teaching, and the profession by helping to provide
veterinary graduates who have more reliably mastered strategically identified competencies.
The project timeline includes two years. Year one work includes development of milestones for learning in the areas of
antimicrobial stewardship and infection control and prevention, and development of modules with outcomes-based
assessments to facilitate students reaching those milestones. Year one also includes development of surveys to assess
student understanding of the concepts taught; surveys will be used to compare the understanding of students completing
courses before and after integration of the modules into preclinical courses. In year two, modules will be integrated into
selected preclinical courses, surveys assessing student understanding will be administered and results analyzed.
This approach is expected to improve student learning and understanding of the key concepts in antimicrobial stewardship
and infection control. We anticipate sharing the results through publication in the Journal of Veterinary Medical Education.
We will create modules that can be used not only in veterinary medical curricula, but also for training and continuing
education of veterinary practice personnel. We expect to provide access to completed modules to partners in the
profession to support their development of individual antimicrobial stewardship programs and infection prevention
protocols and processes tailored to their unique situations.

Public health relevance
Antimicrobial stewardship in veterinary medicine begins with education of future veterinarians and veterinary nurses and is an essential component of veterinary practice, with the goal of improved clinical outcomes and decreased development of antimicrobial resistance. Intentional training and competency-based assessment of the animal healthcare team, both veterinarians and nurses, in their pre-clinical curricula is key. We propose development and implementation of competency-based training modules for antimicrobial stewardship and infection prevention and use of a survey-based assessment to measure improved understanding and knowledge retention.